Examining transitions between cigarettes and other nicotine delivery products among adults in countries with different regulatory environments: the ITC Nicotine Product Adult Survey

SUMMARY/ABSTRACT
The current P01 grant supported the creation of the International Tobacco Control Policy Evaluation (ITC)
Project Four Country Smoking and Vaping Survey, the first international cohort study of smoking and nicotine
vaping product (NVP) use, which was conducted in three countries supported by the P01 grant (United States
[US], Canada, England, plus Australia, which was supported by other funding). Three waves were conducted,
an average of 19 months apart, in 2016, 2018, and 2020. In this renewal application, we build on that work by
matching the extraordinary international expansion of the nicotine marketplace by adding a focus on heated
tobacco products (HTPs) in addition to cigarettes and NVPs. We propose to continue the adult cohort survey in
US (n=2,150), Canada (n=2,150), and England (n=2,300) for 3 additional waves, 19 months apart, over the
next 5 years, with a substantial expansion by adding adult cohort surveys from 4 other ITC countries, which are
being supported by funding sources outside this proposed grant: Japan (n=4,500) and the Republic of Korea
(n=4,700), countries that are the epicenter of the tobacco industry's introduction of HTPs; New Zealand
(n=1,600), which has incorporated NVPs into their “endgame” strategy; and Australia, which continues its
more restrictive approach to these Alternative Nicotine Delivery Systems (ANDS) (n=1,500; grant application
pending). The resulting 7-country ITC Nicotine Product Adult (NPA) Survey (total n=18,900) will represent
an innovative international evaluation system that will allow the research team to conduct a comprehensive
research program on the use of nicotine products, and transitions between cigarettes and nicotine products,
building on the ITC Project's 18-year global experience in conducting rigorous evaluation of tobacco control
policies, employing quasi-experimental analytic methods. The NPA Survey will provide important evidence to
advance the science and understanding of nicotine products and policies during the next five years, which is
certain to be a period of dynamic change in the nicotine product marketplace. Similar studies in the US such as
the Population Assessment Tobacco and Health (PATH) are limited since they do not readily permit cross-
country comparisons using harmonized measures as the NPA survey does. This innovative Project has three
Specific Aims: 1) to describe patterns use of and transitions of use across different tobacco products among
smokers and recent ex-smokers both over time and by key user characteristics within and between countries;
2) to examine how differences in current and future policies (e.g., taxes, flavor bans, product standards, health
warnings) for cigarettes, NVPs, and HTPs are related to differences in patterns of use of these products over
time; and 3) to examine the relative impact of policies on adults and youth (a Specific Aim shared with Project
2). Two exploratory aims will also be addressed given their likely impact on nicotine product use: (a) to
examine how the COVID-19 pandemic is affecting smoking and ANDS use in the 7 countries over time; and
(b) to examine the interplay between cannabis and smoking, vaping, and HTP use over time.

Public health relevance
PROJECT NARRATIVE The rise of alternative nicotine delivery products (ANDS), which include nicotine vaporized products (NVPs; also known as e-cigarettes) and heated tobacco products (HTPs), have led to intense debates regarding whether these products might serve to displace cigarette smoking, thus benefiting public health. The proposed ITC Nicotine Product Adult Survey is a longitudinal study (n=18,900) of adult cigarette smokers and ANDS users in 7 countries (United States, Canada, England, Australia, New Zealand, Japan, and Republic of Korea (South Korea)) that differ substantially in the ANDS that are available and in the ways in which their governments have regulated them. This five-year research project—an extension of our ongoing international longitudinal study of ANDS—will provide unique evidence to inform policymakers about the public health impact of these new products and of the policies designed to regulate them.